PILOT AND FEASIBILITY PROGRAM

DESCRIPTION (provided by the applicant): The UCSF Diabetes Center Pilot & Feasibility (P&F) Program was established 18 months ago to encourage the pursuit of highly novel research for understanding and treating type 1 and type 2 diabetes. The program has been targeted towards all members of the UCSF community - the existing faculty of the Diabetes Center as well as other investigators from other departments and institutes at UCSF - in order to capitalize on the many and varied opportunities within the institution that have pointed relevance to diabetes. The P&F program implemented at UCSF provides investigators with two years of support at $25,000 per year to support conceptually innovative studies. As importantly, these awards are hoped to provide seed funding that will generate sufficient data to pursue additional research efforts through other funding mechanisms. The DRTC P&F Program will endeavor to: 1. facilitate and allow new investigators and junior faculty to establish research programs in diabetes; 2. facilitate and support established faculty wishing to transfer skills and research developments to the arena of diabetes research; 3. foster highly innovative directions in basic and clinical diabetes research, including clinical studies in minority and other underserved patient groups; and 4. foster new and innovative collaborations amongst DRTC UCSF Faculty. The Pilot & Feasibility Program committee is will be chaired by Dr. Douglas Hanahan and the Committee includes Drs. Gerold Grodsky, Michael German and Ira Goldfine. As a group this committee represents all the aspects of the Center to assist the director in the management of the program.